Administrative Core

Core A: Administrative Core PROJECT SUMMARY The Administrative Core will have eight central goals: (a) facilitating interaction and communication along the participating research groups; (b) forming a repository of information for research resources generated by program investigators available to other project investigators; (c) obtaining constructive criticism from extramural and intramural scientists that will help investigators to obtain their research goals; (d) coordinating Resource availability to the broad scientific community (i.e. Resource Sharing); (e) providing biostatistical support to all of the projects; (f) performing the reporting tasks required by the NIH; (g) ensuring appropriate approvals (i.e. radiation, human subjects, animal welfare, DNA) are obtained and adhered to; and (h) providing administrative services to the project as a whole. The Core will be directed by Dr. Evan Keller, fiscal administration and general program activities will be performed by Ms. Roberta Feltner. Dr. Jeremy Taylor and Ms. Stephanie Daignault will provide biostatistical support. These goals will be accomplished by a variety of activities including: - Weekly Project and Core Leader meetings - Monthly Project Team meetings attended by all lab members of all Projects. - Annual one-day visits by our External Advisory Board - Annual one-day visits with our Internal Advisory Board - Biostatistical review of all animal projects prior to initiation of the project to ensure appropriate Power.

Public health relevance
Core A: Administrative Core Project Narrative Bone metastasis is a common problem of prostate cancer that affects many men. This core will oversee the operations of the entire Program to ensure that it moves forward in a direction that addresses this important clinical problem.